Neurology Research Education and Mentorship Program

PROJECT SUMMARY
Physician-scientists are crucial for translating advances in basic neuroscience into clinical care improvements,
yet they face mounting challenges in mastering both clinical medicine and research at the growing complexity.
A major hurdle is the dearth of dedicated time and mentorship for academic research, which has been
addressed by the NIH's UE5 Residency Research Mentorship Program to facilitate aspiring physician-
scientists conducting mentored research during residency and fellowship to pursue K awards. Columbia
University's Department of Neurology has administered this program since 2010, involving Neurosurgery and
Neuropathology departments. Initially, the program boasted a 75% conversion rate to K award, but by the
second cycle, it showed declines. To counteract this decline, three improvement strategies were implemented:
standardized candidate selection, improved training on experimental design training, and sharpening the skills
of grant writing. Promisingly, the last cycle shows progress, with most recipients securing foundation grants
and K applications underway. However, challenges persist, such as insufficient internal funding, leadership
training deficits, insufficient participant diversity, and limited neurosurgery participation. We thus propose to
address these issues in this renewal, and our solutions include creating protocols, enhancing leadership
training, diversifying participation, and improving collaborations with neurosurgery. These initiatives aim to
foster an optimal environment for young physician-scientists to develop a research career.

Public health relevance
PROJECT NARRATIVES Laboratory and clinical neuroscience have advanced markedly in recent years, and there is a growing emphasis on the role of physician-scientists in translating developments in neuroscience into improvements in clinical care. Training young neurologists and neurosurgeons at a formative stage of their careers in research methods will increase the number of committed, successful physician-scientists. This proposal for a renewal of the Columbia University Clinical Neurosciences Resident Research Education Program will provide talented clinical neuroscience residents with the opportunity to develop research skills that have a high likelihood of reducing the burden of neurological disease.